Single-molecule resolution of RNA editing of mRNAs: visualizing GRIA2 editing in situ in ALS

Project Summary Much of the basic biology of mRNA editing remains unknown despite decades of study, largely due to the limitations of existing experimental methods. Adenosine to Inosine (A to I) editing­­a result of adenosine deamination catalyzed by deaminases such as ADAR enzymes­­is one of the most common forms of post­transcriptional chemical modification of RNA, generally known as RNA editing. A to I editing is essential for not only non­coding RNA function, such as rRNA and tRNA higher­order structure stabilization, but also for post­transcriptional mRNA regulation. For example, GRIA2, which encodes the GluR2 subunit of the AMPA glutamate receptor, has a highly conserved ADAR2­targeted editing site in its coding sequence. Perturbation of the orthologous rat Gria2 editing event leads to neurological dysfunction. In humans with Amyotrophic Lateral Sclerosis (ALS), many disease­affected motor neurons appear to die as a result of glutamatergic calcium toxicity and have deficient GRIA2 editing, and Adar2 knockout mice demonstrate an ALS­like phenotype, which is rescued upon exogenous expression of edited Gria2. GRIA2 and several other mRNA A to I editing targets have been studied for more than twenty years, and over the last four years transcriptome­wide surveys of A to I editing have provided evidence for many more mRNA targets. Despite this motivation, much basic information about the biology of this important mRNA regulatory process, including its sub­cellular localization, timing relative to transcription, and association with other regulatory factors, remains unknown largely due to the limits of experimental techniques. Recently, our laboratory described a fluorescence ?in situ ?hybridization method for visualizing and quantifying single­nucleotide variants (SNVs) in single cells using a novel probe hybridization strategy known as SNV FISH. We are leveraging inosine's structure as a guanosine analog to adapt SNV FISH to the analysis of A to I editing in a protocol we refer to as inosine FISH (iFISH). Our preliminary data show that we can use iFISH to specifically identify edited and unedited GRIA2 transcripts i?n situ ?in cultured cells. In this project, we are quantifying sub­single­cellular trends in A to I editing of known targets, such as GRIA2 and mRNA targets newly identified in transcriptome­wide screens. Specifically, we are using iFISH to measure single­cell editing rate distributions, to visualize sub­cellular localization patterns of edited mRNAs, and to measure editing timing relative to transcription. We are also studying the effect of ADAR2 on sub­cellular GRIA2 trafficking. Lastly, we are applying our novel method toward better characterizing perturbations of GRIA2 editing in individual motor neurons in ALS lesions by extending the use of iFISH to fixed sections of post­mortem brain and spinal cord tissue samples from healthy and diseased donors.

Public health relevance
Project Narrative RNA editing is a family of enzyme mediated chemical changes to RNA, perturbations of which are associated with several diseases, including Amyotrophic Lateral Sclerosis (ALS) and epilepsy. Current molecular biological techniques used to study RNA editing are limited in resolution; they can only detect gross changes in large populations of cells and in over fifteen years of use have not been able to reveal precise mechanisms underlying these intriguing disease associations. We have developed a tool to visualize individual RNA editing events in single cells, we are engineering tissue processing techniques to enable its use in fixed brain and spinal cord samples, and we will apply our method toward better characterizing the regulation of RNA editing in general as well as specific editing changes that may lead to motor neuron death in patients with ALS.